Supplement (Covid) to Regulation of endovascular trophoblast cell development and uterine spiral artery remodeling

Project Summary/Abstract No change to the parent project for this supplement request.

Public health relevance
Project Narrative No change to the parent project for this supplement request.